Neural mechanisms of protective effects of early nutrition on the development of social-emotional difficulties among children in Ghana

Project Summary
An estimated 250 million children in low- and middle-income countries are at risk of not fulfilling their
developmental potential, partly due to undernutrition. The long-term goal of this proposal is to inform evidence-
based programs and policies to support children in Ghana and other low- and middle-income countries to grow
and develop to their full potential. This proposal is to conduct a follow-up study of children at age 8-12 years
whose mothers participated in a randomized control trial providing lipid-based nutrient supplements (LNS) to
pregnant women from ≤ 20 weeks of gestation through 6 months postpartum and to their children from age 6 to
18 months (n = 440), comparing outcomes to control groups who received maternal micronutrient capsules
during pregnancy and postpartum (n = 880). The objective is to examine the long-term effect of early nutrition
on brain and nervous system development, while strengthening the research environment and capacity at the
University of Ghana to conduct neurobehavioral and neuroimaging research. The specific aims are 1) To
investigate the effect of LNS on social-emotional development at school age and in the context of children's
home environments and 2) to investigate the potential neural mechanisms through which LNS buffers the
effects of a disadvantaged environment on children's development of social-emotional difficulties. The
hypotheses are that 1) children in the LNS group will have fewer social-emotional and behavioral problems,
compared to children who did not receive LNS, 2) greater effects of LNS will be found in children from more
disadvantaged home environments, and 3) intervention group differences in autonomic nervous system
regulation and white matter integrity measured by diffusion tensor imaging will mediate group differences in
social-emotional development. The rationale is based on the previous finding that children in the LNS group
had fewer social-emotional difficulties at age 4-6 years, with greater effects of LNS in children from
disadvantaged home environments, suggesting that early supplementation buffered the effect of a
disadvantaged environment on the development of social-emotional difficulties in this sample, in which a high
percentage of children had a social-emotional difficulties score in the abnormally high range. Nutrients
contained in LNS, such as iron and essential fatty acids, are necessary for myelination of brain areas involved
in social-emotional regulation and processing, which occurs rapidly during pregnancy and the first two years
after birth. This study will be the first long-term follow-up study in Africa of a randomized trial of both pre-natal
and post-natal nutritional supplementation covering most of the first 1000 days from conception to age two
years, adding to evidence from only two other such studies, both conducted in Latin America (Guatemala and
Colombia) in the 1970s. This study represents an unprecedented opportunity to examine the long-term effects
of supplementation with both macro- and micro-nutrients during most of the first 1000 days using a randomized
controlled design, and the underlying neural mechanisms of the effects of early nutrition on later behavior.

Public health relevance
Project Narrative The proposed study will add to the evidence base for the effectiveness of nutritional interventions during early life, and the long-term return on investment of maternal and child nutrition programs, to inform evidence-based health policy in Ghana and other low- and middle-income countries. Evidence from this study could support investment in maternal and child nutrition as an effective prevention strategy to reduce the burden on the health care system to provide mental health services to adolescents and adults. This is in accordance with the World Health Organization's Mental Health Action Plan 2013-2020 which highlights the importance of implementing strategies for prevention and strengthening information systems, evidence, and research.